Administrative Core

The Administrative Core (ADMIN) for the Center for Social Capital (SoCa) will be essential for meeting the
Center’s mission to reduce cancer health inequities in persistent poverty areas (PPAs) in the New York City
(NYC) Region. The ADMIN will fully leverage the exceptional research and training resources and infrastructure
of Cornell University (CU), Columbia University Irving Medical Center (CUIMC), and Downstate Health Sciences
University (Downstate), and the regional healthcare systems and networks of New York-Presbyterian (NYP)
Hospital System, NYP Dalio Center for Health Justice, Cornell Center for Health Equity, and New York City
Departments of Health and Education, to conduct cancer risk reducing interventions to alleviate cancer health
inequities related to persistent poverty. In order to build capacity and cultivate the next generation of investigators
equipped to achieve cancer health equity in PPAs, the SoCa Center has four Cores to support its’ mission:
ADMIN, Career Enhancement Core (CEC), Developmental Core (DC), and Research and Methods Core (RMC).
The central theme of the SoCa Center revolves around building social capital as a means to alleviate the
impact of systemic factors on health inequities in areas of persistent poverty. We have designed two
complementary projects that focus on novel interventions aimed at two structural determinants of health—
education and health care services (e.g., decreasing the digital divide and linking to cancer control care through
tobacco cessation programs). The ADMIN will oversee, manage, and coordinate the range of activities for the
entire SoCa Center. Within the ADMIN, we will also facilitate the interactions between the investigators involved
in all Center Projects, including the DC pilots, and those led by SoCa Health Scholars, community organizations,
and mentors. The ADMIN will use a coalition approach to support our mission of promoting multigenerational
health and reduce cancer inequities in PPAs. The ADMIN will: (1) centrally manage and coordinate all Center
research and activities to promote synergy and facilitate connections across the Center and will provide
administrative, financial, and scientific support to collaborative research teams across the Center (Aim 1);
monitor research progress and milestones for all Center activities, including all Cores and Projects, and ensure
implementation of the Center Plans through formal feedback and ongoing evaluations (Aim 2); and promote a
community-engaged research agenda, engage early stage investigators in cancer control research, and
disseminate research approaches, methods, findings and opportunities across our NYC Region and through the
larger NCI Persistent Poverty Initiative Network (Aim 3).
The SoCa Center’s ultimate impact in eliminating health disparities in cancer control in persistent poverty
areas in the NYC Region will come from our collective efforts in developing, and building capacity in training and
research opportunities focused on strategies aimed at multilevel interventions that look beyond those focused
on the individual. The ADMIN will support this mission.